Task Area A shall encompass annual follow-up of cohort members, clinical events investigations, study operations, and data analysis and manuscript writing. If implemented, Task A.1 will provide fundin

The Multi-Ethnic Study of Atherosclerosis (MESA) is a study of the correlates, predictors, and
progression of subclinical cardiovascular disease (CVD) in a diverse population-based sample of men
and women aged 45-84 who had no evidence of clinical CVD at baseline. During the initial funding
period of MESA, 6,814 participants were recruited from six Field Centers during 2000-2002 and
examined for evidence of subclinical coronary atherosclerosis, using computed tomography, cardiac
MRI, carotid ultrasound, flow-mediated brachial artery dilation, radial artery tonometry, ankle-brachial
index measurement, and retinal photography. A number of other variables including abdominal aortic
CT, carotid MRI, cardiac MRI tagging for measures of regional myocardial function; established and
putative laboratory risk markers; socioeconomic, psychological, behavioral and environmental
characteristics; and genetic variants were assessed in subsets of the MESA cohort. Examinations of
selected components were repeated over five subsequent examinations spanning approximately 16
years and the cohort has been continuously followed for clinical CVD events since the baseline
examination.

The study will continue to support in-depth ancillary studies that are funded outside of the NHLBI
contract. These studies will be operationally integrated into the main study, and the data will be shared
across the entire “MESA Suite” of studies, per current MESA and NIH data-sharing policies. The
study’s data will be provided to interested investigators through a defined process that encourages
maximum data utilization while protecting participant confidentiality.